Decoding RNA Localization and Local Translation: Key Mechanisms of Cellular Adaption and Function

Project Summary
RNA localization and local translation are vital for cellular function and adaptability. These processes confer
several advantages, such as enabling proteins to be synthesized precisely when and where they are needed,
reducing the reliance on protein transport, protecting RNAs from degradation, and optimizing the cell's energy
use. By coordinating RNA stability, transport, and translation within specific subcellular regions, local RNA
regulation allows for rapid cellular responses to external cues. This is especially important in processes like
homeostasis, differentiation, migration, immune responses, and synaptic plasticity. However, despite these
advantages, several key aspects of RNA localization and local translation remain poorly understood. We lack a
complete understanding of the molecular triggers, conditions, and mechanisms that determine where and when
RNAs are translated or how these processes mediate cellular adaptation. For instance, it is unclear how cells
prioritize which RNAs to translate in response to specific stimuli or how different subcellular regions synchronize
these responses. Local organelle regulation and the timing and regulation of localized translation, especially in
relation to upstream open reading frames (uORFs) and RNA-binding proteins (RBPs), also remain a mystery.
These gaps in knowledge limit our understanding of how cells adapt to stress or adjust to physiological demands.
The proposed research in this application aims to address these knowledge gaps using neurons as a model
system. By leveraging advanced imaging tools and innovative TurboID-mediated proximity labeling approaches,
applied both in vivo and in vitro, this research will illuminate how local RNA regulation influences mitochondrial
function under dynamic cellular demands. Additionally, it will examine how the local molecular machinery shapes
cellular responses and how these mechanisms are conserved or diverge across different species, shedding light
on the evolutionary conservation of these processes. The emphasis will particularly be on identifying this
regulation in response to adaptive stimuli. Comparing adaptive responses across different cell types and species
will also offer crucial insights into how shared and divergent mechanisms determine cellular and organismal
fitness and how disease susceptibility arises. This research application targets foundational questions in cellular
biology and pathology, focusing on RNA-centric mechanisms that play critical roles in neuronal communication
and influence the entire organism. By advancing our understanding of how subcellular RNA regulation and
protein synthesis occur at neuronal junctions, this work aims to provide valuable insights relevant not only to
neuroscience but to general medicine. The findings from this study could pave the way for new therapeutic
approaches that extend beyond neurological disorders, addressing broader cellular and metabolic conditions.
This interdisciplinary approach promises to push the boundaries of RNA biology, offering potential innovations
that could benefit a wide range of medical fields.

Public health relevance
Project Narrative RNA localization and localized translation are necessary for cellular responses and adaptation, yet the detailed mechanisms that govern these processes at the subcellular level remain poorly understood. The research proposed in this application leverages the complex and polarized architecture of neurons to employ advanced imaging and proximity labeling techniques, aiming to uncover the principles of stimulus-driven RNA and translational regulation at neuronal junctions. A deeper understanding of how cells strategically localize and produce essential RNAs and proteins is crucial for developing targeted therapies for diseases caused by cellular miscommunication, such as genetic disorders, cancers, and neurological conditions.